Synthesizing Best Practice to Accelerate Access to Emerging HIV Prevention Modalities

7. PROJECT SUMMARY/ABSTRACT
There are a myriad of new HIV pre-exposure prophylaxis (PrEP) drug formulations and delivery modalities
under clinical development, and it is expected that a range of biomedical HIV prevention options will soon be
available. To enable these options to have maximum public health impact there is an urgent need to create
biobehavioral infrastructure (i.e., empirically validated knowledge, guidelines, and tools) that will: a) allow the
integration of these new options into existing PrEP delivery systems; b) support adherence and retention in an
emerging HIV prevention service system; and c) promote health equity by ensuring that new prevention
options expand HIV prevention coverage to highest priority populations. However, limited research exists that
integrates lessons from existing implementation efforts for oral PrEP and develops data-driven tools that can
be used by research and clinical practice to accelerate diffusion of proven prevention strategies. In response to
that need, the specific aims of this project are to: (1) Synthesize intervention components of PrEP service
delivery models in seven federally designated Ending the HIV Epidemic (EtHE) hotspot counties across the
US, representing diverse geographical contexts, patient populations, and delivery settings; (2) Operationalize
a set of PrEP service delivery process and outcome metrics than can be used to assess fidelity to service
delivery models for daily oral PrEP and emerging modalities and measure progress toward enhancing
biomedical prevention uptake, persistence, and equitable coverage; and (3) Define universal and modality-
specific pre-implementation and implementation activities necessary for settings to integrate emerging
prevention options into clinical practice. This project builds on the past work of the investigative team in oral
PrEP demonstration and implementation projects, development/testing of novel prevention modalities, and
dissemination of evidence-based implementation tools for clinical practice. To accomplish our aims, we will
apply two seminal theoretical models from the implementation science literature, and collaborate with seven
clinical partners in seven EtHE hotspots across the US, as well as a CDC-funded Capacity Building Assistance
(CBA) provider who delivers PrEP training and technical assistance to sites across the country. The knowledge
generated by this project will not only advance the field of implementation science, but also create tangible
tools that can help clinics, heath systems, and policy decision makers improve PrEP implementation outcomes
at a population level. This project has the potential to make a significant and sustained impact on the quality of
future implementation efforts, and the speed with which new modalities are effectively disseminated to highest
priority populations.

Public health relevance
8. PROJECT NARRATIVE This project applies an implementation science approach to support the federal Ending the HIV Epidemic “protect” goal by developing biobehavioral infrastructure (i.e., empirically rigorous knowledge, guidelines, tools) that will support expansion of effective PrEP delivery programs and promote health equity in the dissemination of emerging biomedical HIV prevention strategies. This project is a collaboration among researchers, technical assistance providers, and front-line clinical staff to develop tools and metrics that enhance best practice in the field.